Computations in Human Motor Learning

Project Summary
The long-term goal of our laboratory is to understand the computations underlying human motor learning and
thereby provide a framework to examine the neural underpinnings of learning, the deficits seen in neurological
disorders and how learning mechanisms can be leveraged in rehabilitation. Motor learning is the fundamental
process that involves changes in motor behavior arising from interaction with the environment. Humans spend
a lifetime learning, storing and refining a multitude of motor memories appropriate for different contexts. Current
studies of motor learning have focused almost exclusively on adaptation of individual memories in isolation. Con-
sequently, the principles underlying how the brain coordinates its repertoire of memories are largely unknown.
Our key hypothesis is that the process of contextual inference, estimating the probability with which each exist-
ing motor memory is appropriate for the current situation, controls the creation of new memories and the degree
to which different memories are expressed and updated. Our objective is to understand what leads to the cre-
ation of new memories compared to the modification of existing motor memories, and how existing memories
are recalled and updated. We have developed the COIN (COntextual INference) model to formalize the role of
contextual inference in motor learning. The COIN model performs contextual inference in a more principled and
comprehensive way than any previous model and can explain key findings traditionally attributed to adaptation
as arising instead from contextual inference, such as spontaneous recovery, savings, anterograde interference
and changes in learning rates. In contrast to current models, a critical feature of the COIN model is that it can
determine, in a principled manner, whether a new memory should be created or existing memories adapted. To
both test and develop the model, we will use behavioral studies in humans using novel robotic interfaces and
virtual reality which allow us to control a participant’s sensorimotor experience during motor learning tasks. In Aim
1 we will determine the conditions under which new motor memories are created. In Aim 2 we will determine the
rules by which existing motor memories are updated. While Aims 1 and 2 focus on reaching movements in the
plane which make a large body of previous research comparable, Aim 3 moves towards more naturalistic tasks of
manipulating objects in three-dimensions. In Aim 3 we will determine how motor memories are organized into fam-
ilies to allow efficient learning and generalization for contexts that share similar properties. Voluntary movement
is fundamental to human existence, yet many diseases such as stroke, degenerative disease, and developmental
disorders, impair human movement over the life span. By establishing a new framework of motor learning, this
project will contribute to our ultimate goal of developing assays to understand deficits in neurological disorders
and develop paradigms that can control the contextual inference process so as to improve rehabilitation.

Public health relevance
Project Narrative In this project, we will determine the conditions under which new motor memories are created, how existing motor memories are updated and the rules by which they generalize to new tasks. This project will contribute to funda- mental knowledge on the mechanisms of human motor learning with both empirical work and the development of a novel computational framework for motor learning. This knowledge has the potential to be used to understand deficits in neurological disorders and develop paradigms that can improve rehabilitation.